Dynamic control of mitochondrial function by the protein unfoldase CLPX

Abstract
Mitochondria must maintain and regulate their proteome to meet the varied needs of the cell throughout growth
and development. Mitochondria employ several AAA+ family protein unfoldases as an important tool in
accomplishing this control. We here focus on the AAA+ protein unfoldase CLPX, which can act on its own or
unfold proteins for coupled degradation by its partner protease CLPP. Loss of CLPX is lethal in mice,
mutations in CLPX and CLPP cause mitochondriopathies, and CLPXP drives cancer progression and is
targeted by drugs in clinical trials in a diverse range of cancers. These phenotypes indicate the crucial
contributions of CLPX and CLPP to mitochondrial physiology. The overall goal of this project is to reveal the
mechanisms by which CLPX selects substrates at the appropriate time, thus tailoring their function to
mitochondrial and cellular needs. Proteomic studies have linked CLPX to multiple likely substrates that control
core mitochondrial processes, although only a few have been further characterized, and mechanisms for
conditional substrate selection remain largely undetermined. One of the best-characterized functions for CLPX
is to regulate heme biosynthesis, a crucial mitochondrial function, by acting on the first enzyme in this pathway,
ALA synthase (ALAS). CLPX activates ALAS by partial unfolding to facilitate cofactor incorporation. When
heme levels are high, CLPX (with its partner protease CLPP) also appears to inactivate ALAS by complete
unfolding and degradation, signaled by a heme-binding site in ALAS. In preliminary results, we have
biochemically reconstituted heme-induced degradation of ALAS by CLPXP, confirming the direct nature of this
activity. We additionally discovered that degradation strongly depends on a heme-sensitive adaptor protein.
The project proposed here will (1) elucidate the mechanism by which heme drives assembly and licensing of a
degradation complex for ALAS, using our reconstituted system with equilibrium-binding and kinetic analyses of
complex assembly and ALAS degradation in parallel with observations in cells. (2) We will determine how
heme is directly sensed within the complex using spectroscopic and structural methods and test how the
heme-responsiveness of this system is tuned to suit different cellular programs. (3) We will determine how a
heme-sensitive adaptor in the CLPXP degradation complex tunes substrate selection by CLPX beyond ALAS,
using a candidate-based approach and an unbiased proteomic approach in parallel. This study will reveal
fundamental mechanisms for the conditional control of mitochondrial functions and will provide detailed
molecular targets for the development of therapy for multiple diseases with a basis in mitochondrial function,
including disorders of heme biosynthesis and cancer.

Public health relevance
Project Narrative The mitochondrial protein unfoldase CLPX tunes mitochondrial activity by its selection of protein substrates to unfold and to degrade with its partner protease CLPP. Mutations or misregulation of CLPX and CLPP cause mitochondriopathies, including neurological and blood disorders and drive progression in multiple cancers. Our studies will reveal mechanisms by which CLPX conditionally selects its substrates at the appropriate time or condition, thus describing molecular bases of disease and providing therapeutic targets.